Identifying and Targeting Physiological Assays of Circuit Engagement to Improve Impulsivity

Project Summary
Behavioral inhibition includes our ability to inhibit prepotent, reflexive or perseverative behaviors in the pursuit
of longer-term goals. Impairments in behavioral inhibition are associated with greater levels of impulsivity.
Impulsivity can be classified into at three major categories. Motor impulsivity is measured using tasks focused
on waiting – impulsive subjects cannot wait as long prior to responding. Impulsivity can also be related to
choice – for example, choosing a smaller immediate reward instead of a larger delayed reward. Finally,
impulsive subjects tend to perseverate (i.e. act without thinking), and thus cannot flexibly shift behaviors as
needed when the environment changes. Impulsivity is pan-diagnostic, occurring in attention deficit hyperactivity
disorder (ADHD), drug & alcohol addiction, affective disorders and even neurologic disorders like
frontotemporal dementia.
Various behavioral tasks have been designed to measure the above features of impulsivity. Such models have
been used to test the effects of drugs on minimizing impulsivity. Drugs used in these tasks can modulate
behavior, but not always in a predictable or even replicable manner across labs, strains or species. This has
precluded simple attempts at testing how pharmacologic agents can improve impulsivity. This grant, following
RFA specifications, is focused on assessing whether electrophysiological measures of impulsivity can provide
a more stable “intermediary” measure of circuit activity relevant to impulsivity that can be used for preclinical
pharmacologic testing and development.
The goals of this grant are first to identify neurophysiological (LFP-based) markers of subdomains of
impulsivity described above, with a particular focus on identifying physiological markers that are translationally
relevant and potentially measurable non-invasively in humans. Next, we will assess whether these physiologic
measures can be used as an assay for therapeutic development by testing how the identified physiological
marker changes in response to varying dosages of drugs known to affect specific subdomains of impulsivity.
Finally, using optogenetics targeted at serotonin or dopamine, we will be able to directly test whether
modulation of these neurotransmitter systems in a temporally refined way affects physiology and behavior.

Public health relevance
Project Narrative Impulsivity and compulsivity are core behavioral issues that can exacerbate a wide variety of psychiatric issues, including depression, ADHD, traumatic brain injury and substance abuse. The goals of this project are to identify physiological markers that can be used (instead of or in addition to behavior), as a tool to test for drugs that can ameliorate impulsivity. Thus, we will identify physiological markers of brain function relevant to impulsivity across several tasks; measure whether pharmacologic agents targeting dopamine and serotonin modulate task-relevant oscillations; and finally directly manipulate serotonin and dopamine and measure impacts on physiology and behavior.